HTS with Aspergillus fumigatus for novel, mold-active antifungals

PROJECT SUMMARY
Molds cause devastating infections in diverse patient populations worldwide. The most life-threatening of
these diseases are invasive mold infections (IMIs) which primarily affect immune compromised individuals
including those undergoing chemotherapy, long term steroid treatment, and hemopoietic or solid organ transplant
patients. IMIs can be caused by a handful of environmental molds but the most common species is Aspergillus
fumigatus. Currently, there are three classes of antifungals used to treat IMIs; however, despite available
treatments, mortality rates remain unacceptably high, typically ~50% but reaching 80-100% for some mold
species and patient cohorts. One contributing factor to the high mortality rates is intrinsic resistance of some
mold species to some or all clinical antifungals. In addition, acquired antifungal resistance, particularly among A.
fumigatus isolates, is becoming a clinical problem worldwide.
In the drug development space, antifungal drug screens often focus on yeast species. This is due in part
to the technical ease of handling these organisms in high-throughput settings. Yeast growth is tightly correlated
to optical density, facilitating large-format growth-based screens. In contrast, molds grow as filaments which
create a heterogenous culture of tangled cells whose optical density is not well correlated to biomass.
Additionally, the inability to handle these cultures with automated liquid handling devices creates additional
challenges in high throughput settings. However, the high mortality rates and limited activity of clinical antifungal
against molds warrants more focus on these organisms in antifungal drug screening.
To address the need for mold-active antifungals, we developed and validated a high-throughput
compatible screening assay to screen directly with A. fumigatus. This luciferase-based assay measures the
release of the cytosolic enzyme, adenylate kinase (AK), as a readout for fungal cell lysis. Uniquely, when used
with A. fumigatus this assay can also detect compounds that inhibit germination through the suppression of
background AK release that occurs during normal germination and vegetative growth. Here, we propose a high-
throughput screen of a large library of synthetic, drug-like molecules for novel scaffolds with anti-mold activity
using our AK screening platform. Pilot large-format screens have already identified candidate molecules for
further development; thus, based on the scale and diversity of our proposed screen, we expect to identify
additional mold-active antifungals with novel mechanisms of action for preclinical development.

Public health relevance
PROJECT NARRATIVE Mold infections are a significant cause of morbidity and mortality worldwide, and are among the hardest-to- treat fungal infections due to limited efficacy of current antifungal drugs. There is an urgent need for antifungals to treat these infections and in this proposal, we aim to meet that need by performing a high throughput antifungal drug screen directly with the mold Aspergillus fumigatus. The goal of this work is to identify mold- active antifungal scaffolds with novel mechanisms of action for preclinical development to fight life-threatening mold infections.